The Role of RNA Methylation in the Regulation of Viral Mimicry in Ovarian Cancer

Project Summary
Ovarian cancer (OC) is the most lethal malignancy of the female reproductive system with poor responses to
immunotherapies due to a highly immunosuppressive tumor microenvironment. In contrast, higher levels of
infiltrating lymphocytes are associated with better survival in OC, emphasizing the need to develop strategies
to enhance immune cell recruitment and activation. One strategy is the use of DNA methyltransferase
inhibitors (DNMTis), which include the FDA approved 5-Azacytidine and 5-Aza-2’-deoxycytidine, to increase
the expression of transposable elements (TEs) to promote an antitumor immune response. The removal of
DNA methylation upregulates TEs which form double-stranded RNAs (dsRNAs) that can be sensed by immune
sensors, triggering type I interferon signaling in a response termed “viral mimicry”. Following type I interferon
induction, immune cells are recruited and activated to promote antitumor immunity. However, many cancers
exhibit high baseline levels of TE expression without signaling an immune response. This highlights the
potential role of post-transcriptional regulation, such as RNA methylation, in the negative regulation of the viral
mimicry response. Indeed, RNA methylation, specifically N6-methyladenosine (m6A), has been shown to
promote the degradation of TE RNA and prevent dsRNA formation. In OC, the main m6A writer, METTL3, has
been described as an oncogene. Additionally, other m6A readers are overexpressed compared to normal
tissue and associated with poor survival and reduced immune cell infiltration. These specific aims will test the
overall hypothesis that m6A modulates transposable element RNA to limit dsRNA sensing and
dampens the viral mimicry response. Aim 1 will determine how m6A of TEs change throughout the
transformation of fallopian tube cells, the common cell of origin for high-grade serous OC. Aim 2 will elucidate
the role of m6A in regulating TEs and downstream immune signaling following epigenetic therapy. Collectively,
the proposed aims will investigate the role of m6A in regulating TE RNA and downstream innate immune
signaling during OC transformation and in response to epigenetic therapy. Results from these studies will
provide insight into the potential for pharmacologically inhibiting m6A alone or synergistically with epigenetic
therapy to promote antitumor immunity in OC.

Public health relevance
Project Narrative Ovarian cancer is the deadliest gynecologic malignancy, characterized by a highly immunosuppressive tumor microenvironment. Epigenetic therapies can engage the immune system and promote antitumor immunity through the induction of transposable elements (TEs), but many cancers tolerate high baseline TE expression. The goal of this project is to determine the role of RNA methylation, which has been shown to modify TEs, in the regulation of the viral mimicry response and the potential for synergistically inhibiting DNA and RNA methylation to promote antitumor immunity.